Biomaterial-directed patterning of xenografted brain organoids in-vivo

PROJECT SUMMARY
One of the key challenges in the field of neuroscience is studying the living human brain in-situ which is limited
to non-invasive monitoring techniques in most cases. Human-derived cortical organoids (hCOs), three-
dimensional neural cell aggregates resembling the developing human cortex, have emerged over the past
decade as a powerful tool to model human cortical development and disease in vitro. Unlike animal models,
hCOs capture human-specific features of development and disease and can achieve greater complexity
compared to traditional two-dimensional cell culture models. Extended in vitro culture of hCOs often leads to
necrosis at the core due to inadequate oxygen and nutrient perfusion. However, implantation of hCOs into
rodent brain facilitates xenograft vascularization and maturation of functional neuronal networks. Despite these
advances, hCO xenografts still lack important features of the human cortex, namely cortical lamina, and
preexisting hCO cytoarchitectures become scrambled upon implantation. To permit widespread use of this
technology, there is a critical need to regulate the laminar patterning of xenografted hCOs in vivo in order to
preserve physiologically relevant laminar structures and neuronal circuitry.
To address this problem, I propose to leverage biomaterial, controlled-release technology to deliver
developmental morphogen gradients to xenografted organoids, directing their laminar organization in
situ. These experiments will utilize our recently optimized, cellulose-based polymer (HECMTP), for controlled
morphogen delivery alongside our established techniques for multimodal monitoring of organoid xenografts
using two-photon imaging and electrophysiological recordings. In Aim 1, I will establish biomaterial-directed
gradients of developmental morphogens across hCOs in vitro and identify their effect on hCO laminar
patterning. In Aim 2, I will demonstrate the use of a biomaterial-directed morphogen gradient to guide the
laminar organization of xenografted hCOs in vivo and monitor functional changes in human neuronal networks
as they integrate with the host brain.
This project will be the first to monitor and manipulate xenograft patterning in vivo. Its outcomes have the
potential to enable numerous studies investigating human cortical development in healthy and pathological
states by generating models within a physiologically relevant environment with improved structural and
functional relevance as well as reduced inter-model variability. Concurrently, by working on this project I will
expand my scientific knowledge base, produce high-profile publications, and lay the groundwork for my future
career as an independent investigator.

Public health relevance
PROJECT NARRATIVE Modeling the human brain with accuracy and reliability remains a key challenge in the field of neuroscience and is the basis for our understanding of prevalent diseases such as Alzheimer’s, Parkinson’s, epilepsy, and others. My dissertation project aims to improve a new type of model – xenotransplantation of human brain organoids into rodent cortex – by directing cell patterning and neuronal circuit integration into host systems. Results from this project will establish improved, human-centric models of brain development and contribute to our collective understanding of the molecular mechanisms underlying human brain development.